Deep phenotyping of autonomic dysfunction in chronic kidney disease

PROJECT SUMMARY/ABSTRACT
The overarching goals of this K23 proposal are to improve understanding of the role played by the autonomic
nervous system (ANS) in the cardiovascular (CV) complications of chronic kidney disease (CKD) and to facilitate
the career development of the candidate, Qandeel Soomro MD, MS, a Nephrologist in the Division of Nephrology
at the NYU Grossman School of Medicine. Through a mentored training and research experience, the candidate
will develop the requisite skills and preliminary data needed to become an independent researcher investigating
autonomic physiology in the setting of CKD and testing interventions to prevent the CV sequelae of ANS
dysfunction in this setting. The five-year plan includes in-depth training and didactics in ANS function testing,
causal inference methods, and clinical trial design and operations under the primary mentorship of David
Charytan MD, MSc. CV autonomic dysfunction is an important contributor to cardiovascular morbidity and
mortality in the general population and has been implicated in the strong association of kidney and heart disease.
However, prior studies in the setting of CKD have not investigated the potential causes of ANS dysfunction, have
focused solely on evaluating sympathetic hyperactivity, have limited ANS interrogation to testing of heart rate
variability data, failed to adequately account for the effects of diabetes, and have had limited sample size and
focused solely on dialysis-requiring end stage kidney disease. This incomplete characterization has limited
understanding and the development of diagnostic tools or targeted therapies that could improve CV outcomes
in this high-risk population.
Our overarching hypotheses are that ANS function worsens with decline in kidney function with the phenotype
shifting from a predominantly parasympathetic dysfunction in early stages of CKD to a sympathetic one in more
advanced CKD, that inflammation is a key mediator of ANS dysfunction, and that non-invasive vagal stimulation
will substantially improve ANS dysfunction. Three specific aims are proposed: 1) Deeply phenotype autonomic
dysfunction in CKD using a comprehensive battery of tests longitudinally and cross-sectionally; 2) Quantify the
association of inflammation and autonomic dysfunction in CKD using causal inference methods; and 3) Perform
a pilot trial of trans-auricular vagal nerve stimulation to improve ANS function in CKD. Results from this proposal
will improve understanding of ANS function in CKD, provide initial feasibility and safety data on a novel
therapeutic option, and inform the design of interventional studies to reduce the burden of CV disease and
mortality in a highly vulnerable population. Completion of this K award, will position the candidate for her long-
term goals of improving the lives of patients with CKD by conducting independent investigations into the
physiology and treatment of CV disease in CKD.

Public health relevance
PROJECT NARRATIVE This project will comprehensively characterize autonomic dysfunction in chronic kidney disease and provide pilot efficacy and initial safety assessments of a novel therapy for the treatment of autonomic dysfunction in individuals with chronic kidney disease. Positive results of the proposed studies are anticipated to improve understanding and diagnosis of a common pathology affecting millions of individuals with impaired kidney function and may lead to therapies that improve the poor outcomes in this population.